Investigation of cerebrovascular Notch as a novel modulator of cognitive function

Project Summary
Alzheimer’s disease (AD) afflicts over 6 million people in the United States, and this number is
expected to climb to nearly 13 million by 2050. The development of effective therapeutics is hampered not only
by an incomplete understanding of the pathogenic cascades underlying AD development, but the challenges of
identifying disease-modifying therapies that are also capable of blood-brain barrier penetrance. Increasing
evidence implicates cerebrovascular dysfunction in the pathogenesis of AD, and cardiovascular risk factors such
as obesity and diabetes increase the risk of late-onset AD up to two-fold. Brain microvascular endothelial cells
(BMEC) act simultaneously as a barrier and interface between the central and peripheral environment and
contribute to the regulation of processes such as neurogenesis and neuroinflammation via expression of
angiocrine signaling factors. Dysregulation of neurogenesis and neuroinflammation are associated with AD
pathology as well as obesity and diabetes.
Notch proteins are part of an evolutionarily conserved signaling axis and play critical roles in the
development and maintenance of vascular function. In the brain, dysregulation of endothelial Notch (EC-Notch)
signaling leads to dysregulation of neurogenesis and blood-brain barrier integrity. Our preliminary studies have
found that Notch signaling in the brain endothelium changes with age, is disrupted in AD, and inhibition of
EC-Notch signaling is protective against AD-induced cognitive impairment. Although Notch is a well-described
regulator of angiogenesis, we did not find overt changes in vascular morphology or density in response to Notch
inhibition, suggesting that preservation of cognitive function may result from altered angiocrine signaling to neural
cells. Alterations in Notch signaling are observed in response to, and modulate the course of, diet-induced
obesity (DIO). Thus, dysregulation of EC-Notch signaling in response to DIO may present a mechanistic link
between cardiovascular risk factors and AD pathology.
This study will test the hypothesis that EC-Notch signaling contributes to the dysregulation of
neuroinflammation and neurogenesis during AD and DIO-induced cognitive impairment. Using inducible
genetic inhibition of EC-Notch, we will investigate its role in regulating adult hippocampal neurogenesis and
neuroinflammation in a mouse model of AD, with the goal of identifying angiocrine signaling factors which
mediate these effects. Because Notch signaling is influenced by, and capable of influencing, metabolic
parameters such as obesity and insulin resistance, we will expand our studies to interrogate the role of EC-Notch
in mediating cognitive impairment in response to DIO and insulin resistance. These studies will explore EC-Notch
as a novel, common mechanism of cognitive decline in familial and late-onset AD and interrogate EC-Notch as
a therapeutic target which does not require BBB penetration to exert influence on AD progression.

Public health relevance
Project Narrative Increasing evidence implicates the cerebral vasculature in Alzheimer’s disease(AD) pathogenesis, but exact mechanisms remain unclear. Our preliminary studies have shown that endothelial Notch signaling changes during aging, is dysregulated in AD, and that inhibition of endothelial Notch preserves cognitive function in a mouse model of AD. This project will examine the role of endothelial Notch signaling in regulating neurogenesis and neuroinflammation during the pathogenesis of familial AD, and interrogate whether endothelial Notch signaling links modifiable risk factors for AD such as obesity and diabetes to the onset of cognitive impairment.